Impact of obesity on chemotherapy-induced muscle mitochondrial dysfunction

PROJECT SUMMARY
Obesity increases the risk of cancer; thus, individuals that are obese are more likely to undergo chemotherapy
in their lifetime. However, there is a dearth of literature on the impact of weight status on cancer patient life
quality and functional capacity throughout treatment. For instance, our knowledge of the impact of obesity on
cancer and chemotherapy-induced cachexia - the unintentional loss of lean mass, which directly contributes to
functional dependency, poor treatment outcomes, and decreased survival – is incomplete. An “obesity
paradox” has been postulated; however, the epidemiology remains equivocal on the benefits/detriments of a
high pre-treatment body weight and body mass index. While obesity and cachexia are diseases at opposite
ends of the weight spectrum, these pathologies share some underlying perturbations (e.g. mitochondrial
dysfunction) that may exacerbate functional decrements when these morbidities co-occur. Our lab made the
novel and significant discovery that obese mice, dosed for lean mass, were unable to survive 2-3 cycles of the
chemotherapeutic, 5 fluorouracil (5FU). Indeed, contrary to what has been suggested, we discovered that
obese mice are not protected against chemotherapy-induced cachexia and show exacerbated skeletal muscle
toxicities. Disruptions to mitochondria are 1) central to chemotherapy-induced skeletal muscle mass loss, and
2) are known to be existent with obesity and metabolic dysfunction; however, mitochondrial dysfunction and
resultant functional deficits have not been assessed when these morbidities co-occur. Antioxidants have been
shown to improve mitochondrial function. Indeed, we have shown that the antioxidant dietary compound,
quercetin, can reduce cancer, cancer cachexia, and chemotherapy-induced fatigue, and can increase
mitochondrial function in healthy mice. Thus, quercetin may hold promise as a dietary strategy to treat
cachexia associated with cancer and its therapies in the obese condition. The primary goal of my proposed
F31 is to 1) understand the impact of obesity on 5FU-induced skeletal muscle dysfunction and 2) provide
mechanistic and therapeutic insights aimed at better improving 5FU tolerance with obesity. My central
hypothesis is that 5FU-induced mitochondrial loss and dysfunction is exacerbated with an obese phenotype
and intervening with quercetin will mitigate the deleterious effects of 5FU on skeletal muscle. To test this
hypothesis, I propose three related but independent specific aims: 1) Examine the impact of obesity on cancer
and 5FU-induced cachexia and function loss; 2) Determine the role of mitochondria in obesity-exacerbated
5FU toxicities; and 3) Explore the utility of dietary quercetin on improving 5FU treatment tolerance and off-
target toxicities with obesity. The proposed studies align with my training aims and will provide me with the
opportunity to gain expertise in obesity phenotyping and natural compounds as therapeutics, mitochondrial
health and dynamics, cachexia and functional testing. Further, the professional development training will
promote advancement to the next step in my path to research independence.

Public health relevance
PROJECT NARRATIVE Obesity increases the risk of cancer; thus, individuals that are obese are more likely to undergo chemotherapy in their lifetime. While it is common practice to apply a dosing cap, current recommendations for the treatment of obese cancer patients is full body surface area chemotherapy dosing regimens despite some evidence suggesting that these patients may have exacerbated drug toxicities including perturbations to skeletal muscle mitochondrial function. The primary goal of my proposed F31 is to 1) understand the impact of obesity on chemotherapy-induced skeletal muscle mitochondrial dysfunction and 2) provide mechanistic and therapeutic insights aimed at better improving chemotherapy tolerance with obesity.